Characterization of YcaO-Dependent Natural Product Biosynthetic Pathways

Our group is broadly interested in the chemical biology of natural products with a strong focus on genomics-
based discovery, biosynthetic mechanistic enzymology, and determination of structure-activity relationships and
mode of action. Beyond their historical impact on medicine, natural products have inspired generations of syn-
thetic chemists and provided the necessary chemical probes to illuminate fundamental aspects of biology. One
natural product family that has received increased attention over the past several years are the ribosomally
synthesized and post-translationally modified peptides (RiPPs). While there are over 30 distinct structural clas-
ses of RiPP natural products reported, they are united by a common biosynthetic logic: a precursor peptide,
typically composed of an N-terminal leader and a C-terminal core, is ribosomally produced. The leader region
contains motifs that are recognized by the modification enzymes and the core region is where the modifications
take place. Upon maturation, the leader region is often removed prior to cellular export.
The current project focuses on natural product biosynthetic pathways that encode a member of the YcaO
superfamily. During the original funding period, we showed that YcaO enzymes were responsible for the ATP-
dependent activation of the peptide backbone to yield azoline heterocycles from Cys, Ser, and Thr residues of
the core peptide. During the current funding period, we discovered that two additional reaction types are cata-
lyzed by YcaO enzymes: thioamidation and macrolactamidation of the peptide backbone. No fewer than five
classes of RiPPs are now known to utilize a member of the YcaO superfamily, namely the linear azol(in)e-
containing peptides, thiopeptides, cyanobactins, bottromycins, and thioviridamides. Despite a wealth of
knowledge, we can only predict the modification type of approximately one-third of the YcaO superfamily. Our
bioinformatics analysis suggests that several new reaction types remain to be discovered.
For this renewal project, we tackle several outstanding questions with respect to YcaO-dependent natural
product biosynthesis. Aim I focuses on the structurally and enzymatically intriguing thiopeptide RiPP class. Aim
IA will overcome biosynthetic bottlenecks with respect to substrate tolerance in order to establish the elusive
structure-activity relationships and generate advanced biosynthetic intermediates that will enable the study of
late-stage transformations found within the class. Aim IB will determine the enzymatic mechanism and substrate
scope of the class-defining [4+2]-cycloaddition and establish why some are pyridine-forming while others are
dehydropiperidine-forming. Aim II focuses on peptide backbone thioamidation, in particular, deciphering the func-
tion of the TfuA partner protein and a novel desulfurase/lysase involved in mobilizing sulfur from Cys. Lastly, Aim
III characterizes divergent YcaO family members that appear in unique genomic contexts to discover new reac-
tions catalyzed by the superfamily. Our preliminary data, rich environment, and strong investigative team place
us in an ideal position to address these aims.

Public health relevance
Project Narrative: Douglas A. Mitchell, Ph.D. The genomics revolution continues to pick up speed with bioinformaticians and biochemists struggling to sort through, and make sense of, the avalanche of new information. This project leverages microbial sequencing efforts and focuses on a family of unique enzymes that catalyze modification to the backbone of peptides. Many of these enzymes are involved in natural product biosynthesis whose products hold medicinal value, thus, a greater understanding of these pathways carries biomedical significance.